Region 4, Regional Medical Library and Network of the National Library of Medicine Training Office

Region 4 Overall - Project Summary
The Spencer S. Eccles Health Sciences Library (EHSL), University of Utah, as the Regional Medical Library
(RML) for Region 4, will implement regional and national programs in support of the mission of the Network of
the National Library of Medicine (NNLM) to provide U.S. researchers, health professionals, public health
workforce, educators, and the public with equal access to biomedical and health information resources and data.
This will include training, funding, and engagement opportunities for member libraries and other organizations
to carry out regional and national programs. Region 4 will assess and interpret the needs of current and potential
audiences to expand the reach and impact of the National Library of Medicine (NLM). Region 4 will work with
the other RMLs, Offices, Centers and the NNLM Evaluation Center to cooperatively design, implement, and
evaluate innovative approaches to serving the biomedical and health information needs of researchers, health
professionals, public health workforce, educators, and the public in communities across the U.S., so that all
communities have equal access to the highest level of health information regardless of demographics. The nine
states of Region 4 have a number of commonalities including large rural areas with few cities, Native American
Reservations and Tribal Universities and Colleges, extensive areas lacking internet service, border regions to the
North with Canada and to the South with Mexico, many medically underserved communities and individuals
(MUC/I), and rural hospitals and clinics. Our focus on engaging with libraries and other organizations such as
public health entities and community-based organizations, as well as establishing two-way communications
throughout Region 4, will enable increased outreach, education, and funding designed to improve access to
reliable health information and data. Centrally located within Region 4, the EHSL, as part of the University of
Utah (UU), is uniquely positioned to engage successfully in the work described. As part of the UU community,
we will leverage the affiliations with our hospitals, clinics, schools, colleges, diversity officers, and teaching and
learning specialists to enhance the success of our programs nationwide. We believe that trust in NLM, NNLM,
and RML products and services can only be achieved when the communities served have an authentic and
legitimate voice in how these services are administered. Our proposal demonstrates a sustainable plan to listen
to and partner with current and future audiences throughout Region 4 and the nation to increase access to
reliable health information and improve health equity.

Public health relevance
Project Narrative The Spencer S. Eccles Health Sciences Library at the University of Utah, will implement a 5-year grant to bring quality health, public health, and biomedical information resources within easy reach of the public and all health and public health professionals, with emphasis on medically underserved communities. We will address this charge by improving access to quality health information in Region 4 (Arizona, Colorado, Idaho, Montana, New Mexico, North Dakota, South Dakota, Utah, and Wyoming) while collaborating with other Network of the National Library of Medicine Regional Medical Libraries, Offices, and Centers nationwide.